IROC: Enhancing local enrolling site radiological data capture capabilities for NCTN trials

IROC: Enhancing local enrolling site radiological data capture capabilities for NCTN trials has Budget Details included in the extracted text as well as Personnel commitment time. We think this information should not be reported publicly. It looks like the Abstract appears on page 32 of the eIMG and starts with the sentence "With the evolution of increasingly complex therapeutic interventions in clinical trials as well as the utilization of advanced, more differentiated response assessment strategies, inconsistencies in the local response assessment are being noted when central reviews are performed within NCTN trials" and ends with the sentence, "We now intend to expand and refine these approaches to a national setting. While IROC Ohio will take the organizational lead, we will be working together with the four other IROC QA and support sites as well as the imaging committee of the NCTN groups." The start of the Specific Aims also appear on page 32 and start with the bolded title "A, Development of an in person as well as virtual workshop concept to train response assessors for NCTN clinical trials and ends with the sentence, "We are leveraging the basic IROC Ohio infrastructure both from the technical as well as staffing side to initiate and manage the project that will have active participation from all the other four QA and support sites."

Public health relevance
Budget narrative for training and quality assurance of local readers ability to perform trial specific response assessment for NCTN clinical trials Project Goals With the evolution of increasingly complex therapeutic interventions in clinical trials as well as the utilization of advanced, more differentiated response assessment strategies, inconsistencies in the local response assessment are being noted when central reviews are performed within NCTN trials. Currently, there is no training or quality assurance program in place that could address these challenges in a structured, consistent, and coordinated fashion for the NCTN. This is especially of increasing importance, as imaging used to guide therapeutic management in interventional therapy trials is performed locally and guided by the local assessment. Immune oncological therapies, extended theranostic concepts, as well as the multimodal therapeutic approaches create challenges for consistent response assessment by readers who are not specialized or had not yet enough experience with innovative therapeutic approaches. Such imaging is typically performed as standard of care and may not even be performed at the therapeutic interventional site which has enrolled patient but within more convenient community-based imaging environments. We have reviewed, participated, and analyzed experiences from the EORTC reader training and reader credentialing process and are proposing to perform the foregoing task and investigation in the 12 months project. The IROC Ohio team has been developing, implementing, and performing local training courses for assessors which were either radiologist, nuclear medicine physician, radiation oncologist, surgeons or medical oncologist interested in structured response assessment of the patients they enroll and or take care within clinical trials. The local effort has been coordinated through the local NCTN LAPS leadership. We now intend to expand and refine these approaches to a national setting. While IROC Ohio will take the organizational lead, we will be working together with the four other IROC QA and support sites as well as the imaging committee of the NCTN groups. A, Development of an in person as well as virtual workshop concept to train response assessors for NCTN clinical trials We propose to expand, structure, document and create as well as perform a demonstration in person workshop to train response assessment for NCTN trials as well as record / produce a virtual workshop for self-paced learning followed by a knowledge inventory documentation. B, Develop quality assurance practices and procedures for local readers Quality assurance of radiology reads is frequently performed by peer review when a subsequent reader assesses the quality as well as potential opportunity for improvement of the prior reader. Such processes are not directly applicable to response assessment. While our team has extensive experience in quality assurance of readers for central readers, the traditional additional burden that would not be compensated would not lead to an acceptable participation rate of local readers that read typically fewer cases. While there are several concepts, having a reader assess the reference case is one option like a phantom assessment of an imaging device, however it has the challenge that the images would not necessarily be acquired using the imaging methodology locally used nor would it be readily feasible to have a reference case being reviewed inside the local environment where the reader assesses a standard of care case. We believe that an in-depth analysis of potential different approaches with the potential pro and cons will be necessary in order to map out what may be the most feasible reader quality assurance approach. One of the consistent feedbacks we have heard up to now would be that a trial reader quality assurance effort should be embedded and recognized with continuing medical education credit and or Self? Assessment Module (SAM) credit which is a special designation AMA Category. Our team has experience with such efforts for training and certifying experience with new imaging device technologies. The goal of this effort is to provide current insight into the situation and which option, best practices and procedures could be brought forward as potential implementation strategies managed by IROC for the NCTN. It is the intend to subsequently make the tools and processes available to all the IROC teams and all the NCTN groups and their applicable imaging and operations teams. This effort that has two components which are independent however related. We propose that the supplemental project would be completed within the project period of one year. We are leveraging the basic IROC Ohio infrastructure both from the technical as well as staffing side to initiate and manage the project that will have active participation from all the other four QA and support sites. Budget Details We request the following personnel support for the upcoming budget year for a total of $ 37,979 Michael V. Knopp MD, PhD serves as the co-PI of the U24 Project and PI and Director of IROC Ohio and is requesting 0.24 CM (2%) FTE release time to lead all associated organizational, management and support services as a highly experienced Clinical Radiologist, Nuclear Medicine Physician and clinical trial scientist. As the co-PI of the U24 project, he will provide the leadership, guidance, oversight and active contribution to all parts of the imaging and management aspects of the IROC cooperative and will represent IROC at the NCI NCTN collective management committee. As director of the IROC?Ohio QA Center, he represent the Center at National Clinical Trial Network Group meetings, be active in all aspects of IROC Ohio services lead and provide scientific, technical and administrative direction to its staff for the implementation of existing and new QA programs. In this effort, he will take the visionary and project management lead. Chadwick L. Wright, MD, PhD serves as Co-Investigator and lead senior imaging clinician being boarded in both Diagnostic Radiology and Nuclear Medicine and is requesting 0.24 CM (2%) FTE release time. He is tenure track assistant professor in Radiology and is actively performing clinical work at a below 50% FTE level. He serves as resident clinical imaging expert for all IROC imaging trial related aspects and serves as the lead adjudicator for centralized review as well as for protocol consulting to the national participants. He is a senior Nuclear Medicine Physician with extensive clinical trial and PET/CT experience. He has attended and completed the EROTC Reader training and is an active local and central reader. Zarine Shah, MD (Key personnel) (0.12 CM, 1% FTE) is Associate Professor of Radiology who previously trained in our team and was for more than a year a full-time member of the Wright Center Imaging Corelab. With this, she has extensive clinical trial as well as radiology experience. She is active in abdominal imaging in the clinical service with a special interest in oncology. She performs a large number of SOC reads for patients enrolled in NCTN clinical trials. Andrew Kalnin, MD (Key personnel) (0.12 CM, 1% FTE) is Associate Professor of Radiology with specialty focus and CAQ in Neuroradiology. Dr. Kalnin has been active in clinical neuro-imaging trials including also neuro-functional and spectroscopic imaging. He has extensive experience in all radiologic neuro-imaging areas as a reader and consultant to IROC and will focus on advising for all radiologic neuro-imaging imaging aspects. Ivan Hsieh, PhD (Key personnel) (0.60 CM, 5% FTE) is a research scientist with substantial experience in imaging analytics and quantitative assessment in cross-sectional imaging. He has extensive experience in system programming and IT Cybersecurity aspects. He supports the PI and the team in all IT aspects relevant for the IROC provided services. Richard Jacko, BA, BS (Key personnel) (0.24 CM, 2% FTE) is a research associate with more than 10 years of clinical trial management and quality assurance experience. With a degree and extensive experience in computer science, he also is the lead on IT systems for imaging data transfer, remote access and workflow management. Matthew Orabella, BS (Key personnel) (0.48 CM, 4% FTE) is a clinical research coordinator with experience in in protocol development, protocol management, site and reader credentialing in clinical trials. He has special expertise in the management reader assessment and related analytics. He will be involved in all aspects of this eefort. Timothy Sbory, BS (Key personnel) (0.24 CM, 2% FTE) is a Clinical Research coordinator with substantial experience in protocol development, protocol management, site and reader credentialing in clinical trials. He has special expertise in the management reader assessment and related analytics as well as protocol development for clinical NCTN trials. Lindsay Merrin, BS (Key personnel) (0.60 CM, 5% FTE) is a technologist with experience in in protocol development, protocol management, site and reader credentialing in clinical trials. She has special expertise in the management reader assessment and related analytics. She will be involved in all aspects of this effort. David Smith, BS (Key personnel) (0.48 CM, 4% FTE) is a clinical research coordinator with experience in in protocol development, protocol management, site and reader credentialing in clinical trials. He has special expertise in the management reader assessment and related analytics. He will be involved in all aspects of this effort. Shivangi Vora, MS (Key personnel) (0.48 CM, 4% FTE) is a research associate with substantial experience in clinical trial MRI and central and local site and reader support. She has extensive expertise in the management MRI and Neuro reader assessment and related analytics. She will focus on the Neuro? oncologic specific aspects of this effort. We anticipate the need to travel to in person meetings and are requesting a support of $900 for NIH allowable expenses. After the initial draft development, we will be creating a working group with active participation of the four other IROC sites, IROC Houston, IROC Phili, IROC RI and IROC St.Louis. For the effort from these sites, we request a total cost support of $32,400. The process of fund distribution to the teams will be worked out upon award. IROC is located in an off-campus facility and therefore we request facility / rent recovery support of $2,850 and thus will have only an administrative rate of 26%.